The Contribution of Age-Related Tauopathies to Alzheimer's Disease

Project Abstract
Establishing an accurate neuropathological diagnosis is a critical function of Alzheimer’s Disease Research
Centers and a prerequisite to tissue-based research. Alzheimer’s disease (AD), chronic traumatic
encephalopathy (CTE), primary age-related tauopathy (PART), progressive supranuclear palsy (PSP),
argyrophilic grain disease (AGD), and aging-related tau astrogliopathy (ARTAG) are all age-related tauopathies.
Each has distinctive patterns of abnormal tau deposition and clinical manifestations. While AD is the most
common pathology, the other tauopathies are present in as many as 20% of brains. We recently spearheaded
consensus panels to update criteria to diagnose CTE, PART, PSP, and ARTAG, yet these disorders are not
captured well in the National Alzheimer’s Coordinating Center (NACC) database. During our first funding cycle,
we published 29 manuscripts, showed that 4R immunostaining improves recognition of CTE in early cases and
in young people, and established the roles of 4R and 3R tau, different phosphorylation epitopes, different cell
types, and the utility of our staging scheme in CTE. We identified JADE1 in 4R tauopathies, the distinctive
hippocampal p-tau pathology of CTE, PART vs. AD and uncovered unique neuroinflammatory proteins that
distinguish CTE, PSP and AD. In addition, we showed that deep machine learning-based approaches allow
recognition and quantification of tau and other pathologies and can identify novel regional and cellular features
that predict dementia. We performed single nucleus RNA sequencing of oligodendrocytes and astrocytes in CTE,
established a digital whole slide image (WSI) library of 150 index cases of AD, CTE, PART and AGD and
developed a novel REDcap assessment protocol for tauopathies. Our long-term goal is to advance our
understanding of the neuropathological signatures of the tauopathies to build a foundation for mechanistic
studies that will enable new biomarkers and therapeutic targets. The objective of this proposal is to continue to
identify novel markers for CTE, PART, AGD, and ARTAG, and to expand the scope to include PSP and cases
from underrepresented groups. We will continue to build a digital library of WSI from 600 randomly selected, age
and sex-matched NACC brain donors, including 200 people with normal cognition, 200 with mild cognitive
impairment and 200 with dementia to determine if re-assessment yields previously undetected cases of the age-
related tauopathies. We will examine the contribution of those pathologies to cognitive and neuropsychiatric
symptoms (NPS). In addition, we will determine whether prediction of cognitive impairment and NPS is improved
using supervised and unsupervised deep learning algorithms. We will also use single nucleus RNA sequencing
to examine alterations in gene expression in astrocytes and oligodendrocytes in CTE, PART, PSP, vs. AGD.
This proposal is significant because it will answer a critically unmet need in the study of neurodegeneration, it
will establish the frequency of the age-related tauopathies in the NACC database and determine whether these
tauopathies contribute to the clinical expression of cognitive and neuropsychiatric decline.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will establish the contribution of the age-related tauopathies, including chronic traumatic encephalopathy (CTE), primary age-related tauopathy (PART), progressive supranuclear palsy (PSP), argyrophilic grain disease (AGD) and aging-related tau astrogliopathy (ARTAG) to late life cognitive decline and neuropsychiatric symptoms. This project is relevant to NIA’s mission of improving the health and well-being of older people because it will increase the accuracy of neuropathological diagnosis in mild cognitive impairment and dementia, and will facilitate future research on the diagnosis, treatment, and prevention of Alzheimer’s Disease and related disorders.